Surgical Oncology Training Grant

This application requests continuing support for post-doctoral training in surgical oncology
research for four fellows. The Vanderbilt Department of Surgery has had a continuing
commitment to mentored research for both resident research fellows and surgical oncology
fellows. Given the rapid pace and complexity of both basic and clinical research, it is imperative
to provide trainees with the requisite armamentarium of investigative skills during post-doctoral
training. The establishment of both research proficiency and a pattern of mentored training are
critical for the promotion of successful academic career pathways. Importantly, we have
configured a multidisciplinary training program to allow development of investigators along
basic, patient-oriented, clinical research or bioinformatics tracks. All four of these research
paradigms are considered crucial to the success of broad-based cancer-related investigation.
The objective of this program is to prepare general surgery and neurosurgery residents and
surgical oncology fellows in Urology, Breast and Head and Neck cancer for investigative careers
in research fields related to surgical oncology. Fellows commit at least two years to intensive
training in basic, translational or clinical research through a mentored training environment
necessary for the development of experience and proficiency in investigative techniques and
reasoning. For those interested in basic science research training, opportunities for mentored
investigation are available in the laboratories of scientists with broad interests in cancer biology.
In addition to bench research training, fellows in the basic research track will participate in
didactic course work as determined by the individual advisory committees. Pursuit of a basic
science PhD program is available. Fellows interested in patient-oriented research training may
pursue a Masters of Science in Clinical Investigation (MSCI). The MSCI program combines
broad didactic coursework with a mentored research experience focused on patient related
material or therapeutic intervention. Those interested in epidemiological or outcomes research
may pursue a Masters of Public Health (MPH). The MPH program combines didactic
coursework in clinical epidemiology with a mentored clinical research project. Finally, trainees
interested in computational science may pursue a Masters in Bioinformatics. These four
training tracks allow fellows to pursue the pathways best suited to their career objectives.

Public health relevance
PROJECT NARRATIVE Surgeons remain at the forefront of the care for patients with cancer. The clinical experience of surgeons gives them a particular perspective on cancer. There is a need for research expertise among surgeons and those interested in surgical oncology so that these individuals are fully prepared to tackle the important future research needs in basic cancer biology, translational cancer research and cancer epidemiology.